Project 1: Adipose tissue inflammation in obesity-promoted pancreatic cancer

PROJECT SUMMARY
There is substantial evidence that obesity is a risk factor for the development of several chronic diseases,
including pancreatic ductal adenocarcinoma (PDAC). These diseases pose an incredible economic and
sociologic burden to society. Although the underlying mechanisms are likely multi-faceted, inflammation
certainly plays an important role in the link between obesity and cancer. Infiltrating inflammatory cells as
well as systemic and local levels of pro-inflammatory mediators provide in ideal micro-milieu for tumor
development and growth. Anti-inflammatory strategies have been shown in many animal models to delay or
prevent the development of cancers and are widely considered intriguing approaches for cancer prevention. In
addition, obesity-associated adipose tissue inflammation, in particular visceral adipose tissue inflammation,
correlates strongly to the development of metabolic diseases, e.g. type 2 diabetes mellitus, and (gastrointestinal)
cancer. In previous studies an obesogenic diet was found to significantly accelerate the development and
progression of PDAC precursor lesions (pancreatic intraepithelial neoplasia: PanIN), and to increase the
incidence of invasive and metastatic PDAC in the conditional KrasG12D (KC) mouse model. This was associated
with a substantial inflammation of the pancreas and visceral adipose tissue (VAT). The overarching hypothesis
of this Project is that obesity leads to VAT inflammation, which is a critical (promotional) driver of PDAC
development and growth. Targeting obesity-associated VAT inflammation with FDA-approved, repurposed drugs
may represent an intriguing and novel strategy to prevent PDAC development and progression. In Specific Aim
1 the kinetics of obesity-induced AT inflammation and PDAC development will be investigated. The effects of
diet-induced obesity will be compared with genetically-induced obesity. To identify efficacious interventional and
translational strategies the dose- and time-dependent effects of statins on AT inflammation and PDAC
development will be evaluated in Specific Aim 2. The molecular mechanisms underlying the effects of statins
on AT inflammation and the effects of AT inflammation on PanIN/organoid growth ex vivo will be determined in
Specific Aim 3 with a focus on YAP/TAZ, transcriptional co-activators in the Hippo pathway. The studies will
provide evidence of a critical role of obesity-induced VAT inflammation in PDAC growth and will identify novel
mechanistic pathways and targets. Since statins are widely used and FDA-approved drugs the successful
completion of the studies will have an immediate and translational impact on patients with PDAC. Generally, the
results may also be transferable to other obesity-related cancers and even non-malignant chronic diseases.

Public health relevance
PROJECT NARRATIVE This project is part of a Program Project designed to determine the effects of obesity on tumor promotion in an animal model of pancreatic cancer. We will test the hypothesis that obesity leads to visceral adipose tissue inflammation, which promotes pancreatic cancer development, and investigate the effects of the lipid-lowering drugs, statins, on adipose tissue inflammation and pancreatic cancer development. Our studies will provide the scientific rationale for the use of statins in chemoprevention of pancreatic cancer.